Multidimensional brain connectome features of depression and anxiety

PROJECT SUMMARY
Disrupted communication between brain regions responsible for emotion regulation (limbic and
higher cognitive cortical regions) may critically underlie the emotional dysregulation that
characterizes mood and anxiety disorders. However, the most instructive metric of such
communication has yet to be agreed upon. In addition, due to technical barriers, there are
currently no fine-grained measurements of limbic subregion connectivity in humans. A network-
based approach can be used to explore limbic and cortical subregion connectivity (i.e.
connectome), shedding light on the discrete or shared neural mechanisms underlying core
symptoms in mood and anxiety disorders. In the proposed study we will (1) characterize small
limbic subregions and whole-brain connectomes in healthy controls and individuals with major
depressive and generalized anxiety disorder, by optimizing and employing a novel 7-Tesla MRI
protocol with improved spatial resolution with whole brain coverage; (2) discern network based
biomarkers of depression and anxiety by developing and characterizing a multi-modal
integrative brain network consisting of structural, functional and dynamic topographies using a
new computational multilayer approach; and (3) transdiagnostically examine how connectome
organization manifests across the three study groups. By portraying specific limbic subregion
involvement in the brain connectome, this would advance our understanding of how
connectome alternations manifest in psychiatric disorders. Furthermore, this work combines
high-resolution measures of brain activity and synchronization (functional MRI), with maps of the
brain’s white matter architecture and anatomical connections (diffusion MRI). Their combined
study will facilitate identification of aberrant network features and their contributions to core
symptoms in depression and anxiety. Lastly, the transdiagnostic approach will uncover shared
and unique network mechanisms of depression and anxiety that could potentially provide
improved diagnostics and treatment selection.
This Career Development Award will allow for the critical complimentary training goals
centering on: (1) gaining practical clinical experience towards identifying clinical needs and
conducting translational research; (2) development of technical advanced MRI sequence
development skills; (3) refine computational skills in advanced network science methods. The
proposed research and training afforded by this award will allow me to launch an independent
research program developing neuroimaging methods to study brain network perturbations in
mood and anxiety disorders.

Public health relevance
PROJECT NARRATIVE Mood and anxiety disorders are frequently associated with aberrant communication between limbic and cognitive neural networks, which may trigger emotional dysregulation. We propose to study small subregions of limbic structures such as the hippocampus and amygdala, using combined structural and functional connectomic analysis and determine how they relate to core symptoms of mood and anxiety disorders. A better understanding of limbic connectomic impairments, and how network organization elements capture differences and commonalities across individuals with mood and anxiety disorders, may provide improved diagnostics and inform more effective treatment strategies.